Investigating and Manipulating Cells in Low Oxygen Environments Using Lipid Nanoparticles

ABSTRACT
Low Oxygen Environments (LOEs) are a common characteristic of numerous physiologically relevant
conditions in many different locations in the body. Accordingly, understanding how LOEs impact the cellular
response to technologies that can investigate and manipulate cells is an essential area of fundamental research
that can lay the foundation for advancing health. Recently, lipid nanoparticles (LNPs) have emerged as promising
technologies that can investigate and manipulate cells using messenger RNA (mRNA). Studies investigating the
impact of LOE on mRNA LNP are currently limited, and addressing this key gap in our knowledge will be essential
for understanding how to best investigate and manipulate cells in LOE using mRNA LNPs. Here, we will address
this key gap in knowledge by studying two overarching Research Areas – Mechanism (Research Area 1) and
Tool Development (Research Area 2). In Mechanism, we will perform comparative analyses exploring how
various states of LOE impact the cellular uptake mechanisms of mRNA LNPs across different cell types, mRNA
sequences, and LNP types. In Tool Development, we will develop Low Oxygen Environment Nanoparticles
(LOENRs), a novel class of tools for better investigating and manipulating cells under LOE. This research will
be performed in my laboratory at UNC, an environment that strives to train the next generation of scientific
leaders in a diverse and inclusive environment. In undertaking this approach, we hope our research will provide
key fundamental insights about how cells respond to LOE, a common characteristic of physiologically relevant
conditions that arise in many different locations in the body.

Public health relevance
PROJECT NARRATIVE Low Oxygen Environments (LOEs) are a common characteristic of numerous types of physiologically relevant conditions that arise in many different locations in the body. Studies investigating how LOEs impact the cellular response to technologies that can investigate and manipulate cells are limited. Here, we study the fundamental science behind how cells under LOE respond to mRNA LNPs, an important class of technologies that can be used to investigate and manipulate cells.